A New and Disruptive Gene Based Therapy for Atrial Fibrillation

PROJECT SUMMARY
Atrial fibrillation (AF) is the most common heart rhythm disorder that affects >3 million Americans and is a
major cause of stroke. Since AF is primarily an age-related disease, it is fast becoming an epidemic in a rapidly
aging population. Unfortunately, current therapeutic approaches to AF – both pharmacological and ablation-
based - are sub-optimal in patients with persistent AF. This is thought to be because current treatments do not
target the fundamental, molecular signaling pathways that cause AF. In this Fast-Track SBIR proposal, Rhythm
Therapeutics, Inc (RTI) proposes a radically different approach to AF that targets major molecular mechanisms
underlying AF. Using technology licensed from Northwestern University, RTI proposes an innovative, gene
therapy strategy to target oxidative injury, which is a fundamental, ‘upstream’ biological mechanism that
controls key ‘downstream’ signaling pathways contributing to electrical and structural remodeling in AF. The
technical innovation of RTI’s strategy is two-fold: i) use of NOX2 shRNA to inhibit NOX2, a major enzymatic
source of oxidative injury in the atria and ii) a new, trans-venous method of gene delivery that facilitates
endocardial gene delivery by using electroporation; for this purpose, we will use a catheter (FirMap, Abbott-St.
Jude) that is currently approved for electrophysiological mapping of AF.
RTI’s overarching goal is develop a new, mechanism-guided therapy for AF that has at least 25% greater
efficacy than ablation in patients with persistent AF. The goal of this Fast-Track SBIR is to perform
Investigational New Drug (IND) enabling pre-clinical studies with RTI’s combination product. The hypothesis
underlying this Phase II SBIR is ‘Electroporation mediated delivery of NOX2 shRNA via a trans-venous route:
a) attenuates electrical/structural remodeling in AF in a linear, dose-dependent fashion and b) has a favorable
safety profile’. In Phase I, Specific Aim 1, RTI will determine the optimal electroporation parameters for trans-
venous atrial gene delivery using the FirMap catheter. In Phase II, Specific Aim 1, we will determine the
optimal therapeutic dose of NOX2 shRNA that prevents atrial fibrosis in a heart failure model of AF. In Phase
II, Specific Aim 2, we will determine: a) the optimal therapeutic dose of NOX2 shRNA that reverses
established electrical remodeling in a rapid atrial pacing model of AF and b) the duration of efficacy of NOX2
shRNA in reversing AF in the same AF model. In Phase II, Specific Aim 3, RTI will conduct pivotal toxicology
and bio-distribution studies with its combination product. AF is a $2 billion + market. RTI’s therapeutic
approach, if successful, is expected to significantly improve upon the success of current pharmacological and
ablation strategies for AF, and thereby lead to a paradigm shift in management of AF.

Public health relevance
PUBLIC HEALTH RELEVANCE Atrial fibrillation (AF) is the most common heart rhythm disorder and is a major cause of stroke. The incidence of AF increases with age, making it an ‘epidemic’ in an aging population. Unfortunately, current treatments for AF have low efficacy. In this SBIR, Rhythm Therapeutics (RTI) proposes a radically new treatment for AF that targets a key molecular mechanism – called oxidative injury – that underlie the AF disease state. RTI’s approach will use a novel biological agents (gene) to target this mechanism. This new treatment is expected to significantly decrease the burden of AF in patients that would typically be resistant to current treatments for AF (e.g. ablation, drugs).